SURVEILLANCE EPIDEMIOLOGY AND END RESULTS PROGRAM (SEER)- INDEPENDENT DISCLOSURE RISK EVALUATION OF THE SEER RESEARCH DATABASES

This Call Order provides support for Quality Control and Quality Improvement (QC/QI) activities in the Surveillance Research Program related to SEER database disclosure analysis of re-identification of SEER data